A Software Product That Empowers Individuals Affected By Substance Use Disorders and Their Care Teams with Health and Social Resources

Project Summary
Access and participation in community resource programs such as transportation, housing and medication assistance - also known as
social determinants of health (SDOH) is inextricably linked to a successful treatment and recovery in substance use disorders (SUD).
Therefore, health and social service providers dedicate a significant amount of time to curate local community resource listings or
“referral binders”. These “referral binders” are often highly duplicated and fragmented across organizations and by using expensive
non-scalable solutions technology vendors in this domain have not fully addressed this problem. Furthermore, participation in such
community programs is also hindered by the absence of highly efficient program eligibility screening tools. Undoubtedly, these
shortcomings contribute to lack of direct access to recovery capital for individuals affected by SUD.
We report two feasibility outcomes from our SBIR Phase I study. 1) A novel co-creation led business model that leverages local
partnerships with subject matter expertise agencies on SUD and SDOH - can provide enhanced access to community resource
programs at the point-of-care. 2) A highly adaptive digital assisted SDOH screening tool powered by novel conversational artificial
intelligence (AI) and natural language processing (NLP) technologies can enhance patients’ participation in SDOH related community
programs. This is achieved by using these technologies to perform program eligibility screenings through both web and text messaging
channels coupled with patient triaging within a case work team.
The purpose of this Phase II study is to: 1) Optimize and scale the community resource co-creation business model established in
Phase I by onboarding eight co-creation partners in Texas within 2 years. 2) Examine the relationship between the conversational AI
and NLP powered SDOH screening tool piloted in Phase I with SUD outcomes among youths and young adults. Specifically, we will
partner with the Harris Center for Mental Health and IDD - the largest outpatient mental health provider in Texas to examine whether
youths screened and enrolled into a treatment program using our technology report improved SUD outcomes. As AI and NLP are core
pillars of our technology we will also investigate and subsequently correct for potential societal biases and stereotypes (e.g. race,
gender) encoded in such technologies. This effort will avoid such biases to inadvertently determine outcomes in our downstream
prediction tasks.
The key Phase II milestones include; 1) Demonstrable evidence that the co-creation business model leads to enhanced access to
SDOH and SUD community resources at the point-of-care. 2) An understanding on whether screening and eventual participation in a
treatment program as supported by our conversational AI technology can lead to reduced encounters with law enforcement including
CPS among youths with mental health and SUD. In summary, the proposed Phase II work will lead to enhanced access to SUD
recovery capital and facilitate patients’ participation in local health and SDOH community programs.

Public health relevance
Project Narrative Social factors such as housing, transportation and medication have a significant impact on substance use treatment and recovery outcomes. This Phase II proposal will expand our co-creation model that leverages local community partnerships to curate community resources. In addition, our AI powered digital assisted SDOH screening tool will identify eligible patients and connect them to the services to improve the efficiency of patient screening and intake process.